Dissecting the origin, regulation and function of microglial subsets in Alzheimer's disease

PROJECT SUMMARY
Recent advances in human genetics have unequivocally demonstrated mutations in microglia-specific genes,
such as TREM2 R47H, to be some of the strongest risk factors for late-onset Alzheimer’s disease (AD). These
breakthroughs point to microglia as a potential driver for AD pathology and thus a promising target for novel
therapeutics. Remarkably, single-cell RNA sequencing studies have also uncovered a unique microglial subset,
named disease-associated microglia (DAM), which are found to surround amyloid plaques in mouse models of
AD. Compared to homeostatic microglia, DAM upregulate a cohort of signature genes, including AD risk genes
TREM2 and APOE, which are also elevated in microglial subsets from human AD patients. Despite the apparent
significance of DAM in AD, critical knowledge gaps exist regarding the cellular and molecular mechanisms that
generate DAM as well as the functional contribution of DAM to different stages of AD pathology. The overall-
objectives of this proposal are to determine the cellular origin, transcriptional regulation and subset-specific func-
tion of DAM in AD. As microglial gene loci can be primed at the enhancers, microglial activation may lead to
depositions of certain long-lasting epigenetic marks, which facilitate more rapid changes of gene expression
upon a second hit later in life. Therefore, in theory, developmental activations, as we have observed for prolifer-
ative region-associated microglia (PAM) in the normal developing white matter, may confer naïve homeostatic
microglia such memory at the epigenetic level to allow their faster conversion to DAM in response to disease
signals. Consistently, PAM and DAM share the same transcriptomic signature, which is presumably in turn reg-
ulated by conserved transcription factors. In addition, analyses based on microglial depletion and global mutants
of Trem2 and Apoe (partially controlling the DAM phenotype) have provided important hints for a possible neu-
roprotective role of DAM by compacting amyloid plaques and limiting its spread. However, given the heteroge-
neity of microglia and technical limitations (e.g. DAM resistant to drug depletion), the function of DAM during AD
progression is still controversial. In this proposal, we will test the central hypothesis that conserved transcriptional
and epigenetic mechanisms regulate DAM, which are ontogenically related to PAM and serve as the major
neuroprotective microglial subset in AD amyloid pathology. Aim 1 will delineate the cellular origin of DAM in AD
through genetic fate mapping and epigenetic profiling. Aim 2 will determine the transcriptional regulation of DAM
in AD by transplantation of genetically modified primary microglial cells. Aim 3 will define the function of DAM in
AD via microglia subset-specific manipulations. Upon completion of the proposed research, we expect to have
elucidated the cellular origin, genetic and epigenetic mechanisms as well as in vivo function of the disease-
associated microglia subset in AD. These results will provide mechanistic insights into selective subpopulations
of microglia that may control AD progression, ultimately paving a new avenue for the development of precise
microglia-based interventions to treat AD.

Public health relevance
PROJECT NARRATIVE Alzheimer’s disease (AD) is a devastating neurodegenerative disease affecting about 5 million Americans over the age of 65, and this number is projected to increase 2-3 folds by 2050. Despite the unequivocal genetic links between microglia-specific gene mutations and late-onset AD, how AD-relevant subsets of microglia are regu- lated and how they contribute to AD pathology remain unknown. By investigating these important microglial subsets, this application will shed light on the cellular and molecular mechanisms of AD and lay the groundwork for the development of precise microglia-based interventions to treat AD.